Machine Learning Augmented Discovery of AAV Capsids for Cell Type Specific Access into Human Neurons and Glia

Project Summary
The human brain contains an astonishing diversity of neuronal and glial cell types distributed across dozens of
functional areas. Single cell genomics resources generated by the BRAIN Initiative Cell Census have offered a
wealth of reference knowledge about this diversity, including cell types present in human and non-human primate
brain. However, we currently lack scalable technologies to genetically access these specific cell types, which will
be necessary to advance our understanding of their function.
By leveraging our expertise in viral engineering, single cell analysis, machine learning, and non-human and
human primate neuroscience, we propose to develop a scalable toolkit for accessing distinct cell types in the
human brain. Specifically, our U01 application will develop novel adeno-associated viral (AAV) vectors for cell
type-specific gene delivery using machine learning augmented engineering of capsid libraries. In this pilot grant,
we seek to demonstrate the potential of our approach to support the development of a comprehensive
Armamentarium for brain cell types that would enable functional and translational studies across a broad range
of applications.
In particular, we will apply this methodology to develop AAV vectors for cell types in the human forebrain,
including the hippocampus. Our tools will be openly disseminated after validation for specificity using molecular
and physiological metrics, and mapped onto existing single cell genomics resources from the same brain regions
generated by the BRAIN Initiative Cell Census projects.
If successful, our project will establish a scalable infrastructure for addressing and functionally investigating in
principle any tissue or cell type in the non-human or human primate brain.

Public health relevance
Project Narrative We are developing viral vector and gene expression tools and technologies to genetically address and functionally investigate the role of specific cell types in the human and non-human primate brain. These newly emerging technologies will be molecularly validated and mapped onto existing atlases of cell types in the human brain. To demonstrate their utility, we will validate their capacity to enable optogenetic perturbations of specific neuronal populations in ex vivo human brain tissue. If successful, this pilot project will generate scalable infrastructure that if broadly applicable to any brain region and can support the strategic goals for developing an Armamentarium for brain cell types.